Determining mechanisms of enhanced antitumor efficacy of four-day expanded Th17 cells for adoptive transfer

ABSTRACT

Adoptive T cell transfer therapy mediates potent immunity in patients with bulky metastatic malignancies, but
proves difficult to translate clinically due to production costs, time, and labor required to generate T cell infusion
products. To overcome such obstacles, we proposed a method of shortened ex vivo expansion using Th17 cells
to treat melanoma. Our new unpublished work indicates that Th17 cells expanded only four days ex vivo can
eradicate tumors even when only very few cells (~200K) are infused into the animal. These day-4 Th17 cells
mediate more potent antitumor responses than greater numbers (>25X more) of Th17 cells expanded long term.
In contrast to long-term expanded cells, day-4 cells 1) persist at greater fold once infused in the animal, 2) induce
significantly increased production of multiple cytokines (IL-6, G-CSF, MCP-1, KC), 3) express high levels of
cytokine receptors and costimulatory molecules, and 4) provide long-lived protection against tumor recurrence.
This proposal will determine the mechanism of enhanced day-4 Th17 cell antitumor efficacy and examine
whether 4-days of ex vivo expansion will improve clinical protocols for generating tumor-infiltrating lymphocyte
(TIL) products with superior efficacy. Based on our findings, we propose the central hypothesis that day-4
expanded Th17 cells possess enhanced efficacy in vivo due to their unique ability to recruit other immune cells
to the tumor as well as form durable memory. To test this hypothesis, in Aim 1, we will examine the effects of IL-
6 on shaping memory and antitumor activity of Th17 cells via neutralization versus exogenous supplementation
of IL-6. In Aim 2, we will determine whether the antitumor efficacy of very few day-4 Th17 cells is reliant upon
host immunity through antibody depletion of host neutrophils, macrophages, NK cells, and lymphocytes. Finally,
in Aim 3, we will assess the functionality of TIL products kinetically during ex vivo expansion and determine
whether 4-days of rapid expansion is superior to clinically standard 14-days. These investigations are
expected to expose key mechanisms underlying short-term expanded Th17 cell potency to 1) identify
novel approaches to improve ACT with long-term expanded cells and 2) highlight shortened expansion
as an efficient, less expensive method for future ACT (recently FDA approved at a cost of
>$500,000/infusion).

Public health relevance
Adoptive T cell transfer therapies are a promising approach for treating aggressive solid tumors; however, these therapies are extremely expensive and time consuming which prevents widespread availability to patients with end-stage malignancies. We discovered that Th17 cells expanded only four days regress large solid tumors in very low number and seek to understand mechanisms behind their enhanced efficacy. Our mechanistic studies will allow us to harness these pathways to elicit robust, prolonged immune responses against cancer in a more rapid and efficient manner, permitting greater public access to adoptive transfer therapies.